Geriatric Oncology: Cognition and Communication

An important public challenge is how we address the multi-layer complexities associated with individuals who have a cancer diagnosis and cognitive impairment and/or functional deficits. Many organizations including the American Society of Clinical Oncology and the National Academy of Medicine (formerly Institute of Medicine) have recognized the need for more research and education about the diagnosis and management of geriatric syndromes in patients with cancer as many healthcare providers (HCPs) are unprepared. The Geriatric Oncology Cognition and Communication (Geri-Onc CC) training program has been designed to train oncologists, primary care providers, and other HCPs (nurses, nurse practitioners, physician assistants, social workers, physical therapists, occupational therapists, etc.) to screen for and conduct an initial assessment to identify cognitive impairment and/or functional decline in the older cancer patient, to learn about factors to consider when treating older cancer patients, and to improve communication with the patient and his/her caregiver. The first 5 years of Geri-Onc CC have been highly successful in terms of the ability to recruit HCP’s from a variety of clinical settings and participants’ ratings of the program, their increased knowledge and self-efficacy, and demonstrated improvements in their communication skills. In this renewal, we plan to build on this success and continue to train the workforce in how to work with older adult cancer patients. Two hundred eighty-eight HCPs working with older oncology patients will participate in the interactive, multi-modal two-day program with ongoing professional development over a 12-month period. Training will occur in 12 cohorts over the 5-year project. We will examine knowledge, attitudes, and use of skills before and these variables as well as uptake and use of communication skills and transfer of learning and skills to the HCPs’ clinical setting up to 12 months after the training. The overarching goal of this cancer educational program is to prepare the workforce to care for this growing, vulnerable, aging population.

Public health relevance
The goal of the renewal of this cancer education training project is to continue to train healthcare providers (HCPs) of all clinical disciplines to work more effectively with older cancer patients who may have cognitive and functional difficulties. This project is important because it will help prepare the work force to care for the growing numbers of older cancer patients and their families. Results of this study have the potential to improve the knowledge and communication skills of oncology HCPs which will benefit HCPs and older oncology patients and their families.